Mechanisms of Chaperone-Mediated Control in the Assembly of the Proteasome Holoenzyme

PROJECT SUMMARY
The proteasome is a complex molecular machine and an essential mediator of ubiquitin-dependent
protein degradation. Polyubiquitination of target proteins has been long considered the major regulator of proper
protein degradation. However, little is known about a new and potent regulator of cellular protein degradation —
mechanisms that control the rate and quality of proteasome assembly. It is well established that cells require
multiple evolutionarily conserved chaperones to regulate proteasome assembly. A catalyzed assembly
mechanism serves as an active regulator of proper proteasome assembly, and therefore of proteolysis itself.
Under some pathological situations, cells are known to exploit these chaperones to alter the rate of proteasome-
mediated proteolysis. Moreover, chaperone-mediated assembly of proteasomes has also been linked to major
pathways for growth control. Therefore, understanding how chaperones control proteasome assembly is of wide-
ranging biological and biomedical significance. The objective of this proposal is to elucidate how these
chaperones function to regulate the rate and the quality of proteasome formation. Our central hypothesis is that
the chaperones determine correct versus incorrect assembly of the proteasome by regulating both the ATP
hydrolysis and the ubiquitination of the ATPase subunits en route to proteasome formation. Aim 1 will determine
how chaperone-mediated inhibition of ATP hydrolysis by the proteasome subunits controls proteasome
assembly events. Both in vitro and in vivo proteasome assembly assays will be used while the ATPase rates are
directly modulated by specific yeast mutants. Aim 2 will determine how ubiquitinations of the proteasome
subunits provide quality control during chaperone-mediated proteasome assembly. Biochemical approaches
similar to Aim 1 will be used in combination with yeast genetics. The goal is to identify how the chaperones
regulate ubiquitination of the proteasome subunits, and how ubiquitination affects assembly intermediates and
the assembled proteasome holoenzyme. The expected outcome is the identification of the mechanisms by which
the chaperones determine incorrect versus correct assembly events, and provide quality control, thereby
enabling only the correct assembly events to proceed in forming the proteasome holoenzyme. The proposed
research is innovative because it aims to identify mechanisms that regulate the number of functional
proteasomes in the cell, which have been missing from the current paradigm of proteasome-mediated proteolysis.
This contribution is significant for human health to help understand how this critical pathway is exploited to alter
protein degradation in pathological conditions, including cancer, neurodegenerative disease and aging. These
conditions are known to be impacted by the ubiquitin-proteasome system, a proven therapeutic target for altering
protein degradation in disease. We anticipate that understanding chaperone-mediated regulation of the
proteasome subunits will contribute to the development of new targeted drugs.

Public health relevance
PROJECT NARRATIVE The proteasome is a central mediator of protein degradation, and has been connected to cancers and neurodegenerative syndromes. The proposed research aims to unravel how cells generate the proteasome at the proper rate and the quality to control the number of functional proteasomes for protein degradation. This study contributes to public health by providing the fundamental basis of exploitation of the proteasome in human diseases, and for strategies to combat them.